Inflammation and retinopathy of prematurity

PROJECT SUMMARY
Retinopathy of prematurity (ROP) is among the most common morbidities affecting premature or low
birth weight infants and is a major cause of long-term visual and non-vision related morbidity. ROP is a
disease of low birth weight survivors, but is often preceded temporally by inflammatory conditions in both
the prenatal and postnatal period. Limiting exposure to excess oxygen and the recent advent of anti-
angiogenic compounds are the foundation of ROP treatment, but these approaches are compounded by
increased mortality and poorer cognitive outcomes in low birth weight infants who are maintained at
lower supplemental oxygen or received bevacizumab (anti-VEGF) for ROP. These findings indicate a
poor understanding of disease pathogenesis and contribution of co-morbid diseases and inflammation to
ROP development. Clinical observations of persons at risk for retinal neovascularization and
inflammation, as seen in neurofibromatosis type 1 (NF1), suggest that inflammatory monocytes and
macrophages play a vital role in aberrant retinal angiogenesis and ROP. Neurofibromin, the protein
encoded by the gene causing NF1, functions as a master regulator of macrophage polarization, and
inactivating mutations in the Nf1 gene result in mobilization of pro-inflammatory monocytes and
macrophages in mice and humans. Neurofibromin-deficient macrophages take on a distinct molecular
and metabolic phenotype, characterized by enhanced production of reactive oxygen and nitrogen
species and over-dependence on glycolysis via upregulation of phosphofructokinase-1 (PFK-1) activity.
Further, neurofibromin-deficient macrophages are pro-angiogenic, but also support pathologic retinal
neovascularization. In Aim 1, we will interrogate neurofibromin-regulated pathways that induce
inflammatory macrophage polarization to identify how they promote endothelial cell proliferation,
migration, and capillary formation. Aim 2 will examine glucose uptake and utilization in neurofibromin-
deficient macrophages using in vitro and in vivo techniques with specific focus on macrophage
metabolism as a therapeutic target for the treatment/prevention of retinal neovascularization. Finally, in
Aim 3, we will capitalize on pilot data demonstrating a mobilization of inflammatory monocyte subsets in
neonates with severe ROP. Here, we will longitudinally examine circulating inflammatory monocytes in
neonates “at risk” for severe ROP to identify discrete monocyte subsets as a biomarker for ROP and
define the contribution of neurofibromin-regulated signaling to inflammatory monocyte mobilization in
neonates with ROP. At their conclusion, the proposed studies will define the contribution of inflammatory
macrophages to pathologic retinal neovascularization and identify a biomarker for severe ROP requiring
treatment.

Public health relevance
PROJECT NARRATIVE Inflammation plays a key, yet poorly understood role in retinopathy of prematurity (ROP) development, which affects over 50% of infants designated as very low birth weight (less than 1,500 grams). We have discovered a novel protein, neurofibromin, that suppresses inflammation, and decreased expression of neurofibromin enhances inflammation and pathologic retinal angiogenesis in mice and humans. The major goal of our studies is to establish neurofibromin-regulated pathways that promote inflammation as novel therapeutic targets for ROP and determine the reliability of inflammatory monocytes as biomarkers for early, severe ROP.